Visualizing and predicting new and late HIV diagnosis in South Carolina: A Big Data approach

Abstract
Although many notable strides have been made in HIV prevention, the current pace of progress in the US,
especially in the Southern states, is too slow to achieve the goals laid out in “Ending the HIV Epidemic: A Plan
for America” (EtHE). The success of effective HIV interventions demands more precise and timely surveillance
of the epidemic, especially for the HIV clusters and outbreaks as indicated by a large or an increase in number
of new and/or late diagnoses among certain key populations or geolocations (“hotspots”). However, some
critical gaps remain in our current HIV surveillance and targeted prevention efforts. These gaps include a lack
of timely prediction of HIV risk that is needed for a rapid public health response, reliance on data from limited
sources in identifying the hotspots and predictors of new infection clusters, and a lack of efforts in utilizing
various data sources to inform the selection and delivery of targeted prevention and control at state and local
levels. To develop more effective, timely, and targeted approaches for HIV prevention, it is critical to develop a
data-driven surveillance and prediction system of new and late diagnoses so that the local health departments
and healthcare systems can rapidly identify priority populations and geolocations where HIV is spreading, or
our prevention efforts are lagging behind. Building on an integrative multi-level data structure and a strong
academic-government partnership, we propose the current study to strengthen the understanding and
visualization of HIV infection clustering, enable the prediction of outbreaks, and contribute to the optimization
of strategies to deliver evidence-based prevention. In close collaboration with the South Carolina Department
of Health and Environmental Control (SC DHEC) and other stakeholders, we will integrate multi-level data
sources, including statewide electronic health records data, county-level contextual data, geospatial data, and
social media data, to predict new and late HIV diagnoses in SC and develop an interactive web portal to
visualize the spatiotemporal patterns and trends of new and late HIV diagnoses in SC across geolocations and
over time, particularly in the context of unanticipated HIV service disruptions by COVID-19 and other future
public health crises. Using a Big Data approach and the integration of multi-level data sources, the proposed
research will provide a better understanding and visualization of the dynamic spatiotemporal patterns and new
case predictions. The prediction models and the interactive web portal will assist SC DHEC, AIDS service
organizations, and other healthcare systems to rapidly identify, characterize, and predict new HIV clusters and
to deploy targeted HIV prevention and control efforts in a timely fashion.

Public health relevance
Project Narrative HIV cluster and outbreak detection and response remains a fundamental strategy in the national and local EtHE implementation plans. The proposed research will generate data-driven evidence on the contextual drivers and other predictors of new and late HIV diagnoses in different groups (age, gender, race/ethnicity), locations, and contexts (e.g., COVID-19 pandemic or other social interruptions). With this evidence, local health departments and healthcare systems can rapidly identify the hotspots and priority populations of new and late HIV diagnoses in SC and inform the selection and delivery of targeted HIV control strategies towards the goal of ending the HIV epidemic in SC and other Southern states in the US.